National Xenopus Resource Center

Project Summary
This project supports continued funding for the National Xenopus Resource (NXR) located at The Marine
Biological Laboratory in Woods Hole, MA. The NXR is one of the top priorities for the Xenopus community. The
NXR was established in 2010 to serve as a national resource for researchers working with the Xenopus
amphibian model system, which includes two species Xenopus laevis and Xenopus tropicalis. The NXR also
serves as a national repository for community-generated animal stocks as well as serving as an advanced
training venue that greatly facilitates productivity for a multitude of researchers. It is a community-oriented
resource center that serves all Xenopus researchers, including individuals from large research-focused
universities to small liberal arts colleges. As biological research becomes ever more complex, often requiring
specialized animal lines and involving diverse technologies, individual laboratory units become insufficient to
meet all the demands required for addressing significant biological problems and a centralized repository or
stock center becomes essential. The NXR will maintain current stocks of frogs as well as obtain new lines making
them available to the community; this includes special inbred, wild type and mutant lines of both species. During
this project period, we will improve the NXR website and link it with the Xenopus model organism database,
Xenbase.

Public health relevance
Project Narrative Research using the amphibian Xenopus, because of unique advantages as an experimental system, has revealed key insights in many domains of biomedical research, including cell biology, development, neurobiology, physiology and signal transduction, achievements that are supported by having a centralized National Xenopus Resource for raising and distributing animals and disseminating the most current technology to the research community. In each of these areas research has led to significant insights about the causes of human diseases, including cancer, birth defects, diabetes and neurological disease, and provided key underpinnings for the field of regenerative medicine.